Administrative Shell

The administrative shell has an organizational rather than a scientific focus. While the goals of the individual Cores are to serve the user base, the goal of the administrative shell is to serve the individual cores, overarching needs and the overall Research Core Center mission. The charge to the administrative shell is therefore to: Specific Aim 1: Integrate and supervise the Research Core Center activities Specific Aim 2: Facilitate the operation of the individual cores by resolving issues of space and facilities Specific Aim 3: Assume administrative tasks for all cores such as personnel management and financial operations Specific Aim 4: Carry out or facilitate contacts with University of Michigan administration and granting agencies Specific Aim 5: Coordinate and facilitate the submission of progress reports and renewal grant applications Specific Aim 6: Track user group research and publications associated with their use of the Core Specific Aim 7: Coordinate training across Core components Specific Aim 8: Coordinate and maintain the Research Core Center web site

Public health relevance
The purpose of this grant is to enhance and extend the research of multiple investigators towards increasing the understanding of disorders of hearing, balance, taste and smell and developing the ability to prevent and treat these disorders. It will also provide mechanisms to encourage and increase collaborations among its research base, bring new researchers into the field as well as educate the user base on new methods and approaches.